ADMINISTRATIVE CORE

This core will provide administrative support for all of the projects in the Program Project. Secretarial help for manuscript preparation for publications related to the studies supported by the Program Project as well as annual progress reports will be provided to all the projects. The organization of monthly group meetings as well as visits by the external speakers will be arranged by this core. The administrative assistant for this core will also be responsible for maintaining a web site and for working with the budget administrators of the 3 different departments involved in this Program, as well as ensuring that all the administrative, financial and other requirements of the NIH and NIAID are met. Dr. Lambris will supervise this core.